Development of Validation of a Novel Software Platform for Decentralized Clinical Trial in Substance Use Disorder Incorporating Large Language Models

Abstract
Substance use disorder (SUD) clinical trials traditionally perform recruitment, enrollment, interventions, as well
as information collection at the clinical trial sites. In-person visits at the sites are used for screening,
assignment to interventions, treatment, or other intervention, follow up, as well as collection of information from
participants and entering it in a database. Requirements for participants to be physically present at the study
location may be limiting the diversity of the participants in the trials due to a variety of factors including, for
example, time to travel to the center, loss of time from work, transportation issues, child, and elder care
responsibilities. The perception of stigma associated with participating in a SUD trial can also prevent
participation. These factors often hamper engagement, recruitment, screening as well as retention in trials. In a
survey of clinical trials participants, it was found that they most often dislike the location, the length of the visit
and time commitment. Decentralized clinical trials (DCTs) allows for most of the visits to be converted into
telehealth visits and/or phone calls. The monitoring, when needed, is done with equipment delivered to the
patient's house or at local clinical laboratories and/or health care providers. Wearable devices have
demonstrated sufficient accuracy in many monitoring tasks such as steps or heart rates. This approach may
solve the commuting problem and decrease the loss of time from work and home care issues. However, there
are still gaps that prevent the utilization of DCT in SUD mainly due to the heterogeneity of the data and
difficulty for the clinical trial coordinators to go through all pieces of the data to ensure the accuracy of every
entry. Current clinical trial platforms do not offer a good support for DCTs in SUD. On another end, the
development of large language models (LLMs) has shown significant potential to function like a human in
natural language processing (NLP) tasks including sematic analysis and text generation. By finetuning an
existing LLM with specific knowledge, such as SUD, it can perform better at this domain and can potentially
automate many communication and data collection tasks, which are traditionally performed by human experts
such as the clinical trial coordinators. In this project, we aim to develop and validate a novel software platform
that will specifically solve the challenges in DCT under the context of SUD and leverage the cutting-edge LLM
technology to improve efficiency and accuracy of data collection. In the Phase I period of this project, we aim to
perform feasibility testing with the following two aims: 1) develop a novel software platform for DCT in SUD
with fine-tuned LLM, 2) validate the LLM accuracy and software usability in an emulated SUD trial using
retrospective data. By addressing the technical and practical challenges of DCT and leveraging cutting-edge
technology, this project has the potential to shift the clinical paradigm for SUD clinical trials to encourage more
participants from all background and lead to improved SUD treatments for all patient population.

Public health relevance
NARRATIVE This project aims to develop a software platform for decentralized clinical trials specifically in the substance use disorder. It will also incorporate a large language model to improve the efficiency and accuracy of data entry. This platform has the potential to enable much efficient trials to recruit substance use disorder patients of all background.